Leadership, Planning and Evaluation

PROJECT SUMMARY: LEADERSHIP, PLANNING & EVALUATION
Dr. Gary Gilliland, the Consortium Director, creates the overarching vision for the Fred Hutch/University of
Washington Cancer Consortium. To accomplish this, he engages internal and external leaders, committees,
and individuals to help define this vision and to chart the short and long-term steps needed to move towards
this goal. Structures have been created to help assure that the plans of the Consortium are congruent with
those of the member institutions. With the help of Consortium Administration, methods have been developed to
monitor the activities of the Consortium as directed by the planning process and to help assure that these
activities are communicated to Consortium members. Robust processes have been created to evaluate
progress made in achieving the goals set out in the planning process, report the results of the evaluations back
to involved members, review responses to the evaluations, and evaluate the outcomes of those responses.
The specific aims for Leadership, Planning & Evaluation are (1) with input from internal and external experts,
to identify those areas where investments of time and resources are most likely to assist the Consortium in
achieving its mission to eliminate cancer as a cause of suffering and death; (2) to create a structure that
engages all Consortium partners in planning so that individual institutional objectives are well aligned with
Consortium objectives, (3) to continuously monitor and communicate Consortium activities to all stakeholders,
and (4) to create an iterative process for evaluating Consortium activities, providing feedback, reviewing
responses to feedback, and revaluating subsequent outcomes.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.